Community Engagement: A Short Course to Optimize Research Endeavors (CE-SCORE)

Project Summary
Community engaged research (CER) is a historically underutilized approach in behavioral and social science
research (BSSR). Further, when utilized by BSSR researchers, CER has traditionally been conducted in a top-
down approach, with researchers designing studies and collecting data without input or consent from the
communities involved in their studies. This top-down approach has been criticized for being paternalistic, and
for not meaningfully including the perspectives, lived experience, and expertise of community members.
Moreover, BSSR has often been used to justify policies and programs that have had negative consequences
for communities, especially for those who are marginalized. This has led to a mistrust of behavioral and social
science research within marginalized communities. However, there is a growing movement in BSSR to adopt
CER approaches. These approaches involve working directly with communities to identify research questions,
collect data, and interpret results. It also involves sharing research findings with communities and using them
to develop programs and policies that benefit communities. By engaging with communities, researchers can
improve the quality of their research, increase the impact of their research, and build trusting relationships
between researchers and communities. While institutions may now be adapting their curricula to include topics
such as community engagement, health equity, and related methodologies, this subject area is not universal
across BSSR education. Thus, there is ample opportunity for research education programs, such as short
courses, to create shared community learning spaces for reflection, mentorship, and practice between BSSR
scholars, students and health practitioners. In response to “Short Courses on Innovative Methodologies and
Approaches in the Behavioral and Social Sciences” (RFA-OD-23-003), we propose “Community Engagement:
A Short Course to Optimize Research Endeavors” (CE-SCORE). This short course will utilize the principles of
critical adult education (CEA), a form of adult education that aims to empower learners to critically analyze the
world around them and take action to transform it. CEA asks learners to consider power relations and
ideologies, such as those between scientist and citizen, in order to allow the learner to reflect on their current
and future research practices. In this way, CEA and CER are aligned in their concern with community
empowerment, social justice, and social change to create a more just and equitable world. CE-SCORE
promises to empower students to critically engage with CER principles, and learn to apply them in real-world
settings that are relevant to students’ community contexts. The teaching methodologies and course curriculum
will empower emerging and current public health scholars, students, and practitioners to reflect on their current
practice, and learn to enact CER values, in order to transform the world around them through research.

Public health relevance
PROJECT NARRATIVE Community Engagement: A Short Course to Optimize Research Endeavors (CE-SCORE) will enhance the knowledge and skills of contemporary behavioral and social science researchers (BSSR) around community- engaged research and practice to advance public health goals in the United States. Current students, scholars, practitioners, and educators at various stages of their careers will engage in critical adult education learning cohorts and join a new community of practice. This community of practice will foster multi-directional mentoring relationships between students, scholars, practitioners and educators to sustain an intentional focus on prioritizing community agency in BSSR scholarship and practice.